DiaBetter Together: A Strengths-Based Peer Mentor Program to Support Young Adults with Type 1 Diabetes During the Transition from Pediatrics to Adult Care

PROJECT SUMMARY/ABSTRACT
Type 1 diabetes (T1D) management is challenging for young adults, who assume responsibility for self-
management and transfer T1D care from the pediatric to adult healthcare system as they also manage typical
developmental demands (e.g., social, financial, work/school, residential). Many young adults have extended
(>6 months) gaps before following up in adult care, which increase their risk for poor health outcomes and
serious health complications. There are few evidence-based programs to support young adults with T1D during
the transfer period between pediatric and adult care. Novel, developmentally appropriate approaches are
needed to help young adults negotiate the challenges of living with T1D and complete a timely transition to
adult care. The goal of the proposed study is to evaluate a new intervention for young adults with T1D that
maximizes diabetes-related social support. The proposed transition intervention builds on young adults' social
support network and provides them access to relevant information about T1D care in adulthood. Around the
time they leave pediatric T1D care, young adults with T1D will be paired with a trained “Peer Mentor,” an
experienced, slightly older young adult with T1D, who will meet with them in-person and have frequent (weekly,
then monthly) contact for 12 months. During the contacts, the Peer Mentor will use strengths-based
psychoeducational strategies to teach and model problem-solving and stress-management skills, encourage
the young adult to seek support from their existing social support network (e.g., family, friends) and identify
new sources of diabetes-related support, help the young adult prioritize T1D self-care during the very
demanding young adult period, share his/her transition experiences and strategies for successfully navigating
the adult healthcare system, and prepare for the first adult care visit. The Peer Mentor will be a positive role
model and source of help, encouragement, and accountability around transition, with the goal of reducing
isolation, promoting self-management, and preventing gaps in care. We will test this intervention with 150
young adults randomly assigned to the intervention or usual care. Our main goal is to evaluate the
intervention's impact on important T1D outcomes, such as glycemic control, time to adult care, treatment
adherence, and psychosocial well-being. Clinic appointment information, questionnaires, adherence data, and
glycemic control biomarkers will be collected at baseline and 6 and 12 months later. The ultimate goal of this
research is to validate a supportive intervention that can facilitate T1D self-management and transfer of care
during the difficult young adult years and promote optimal T1D health outcomes.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes (T1D) management and the transfer from pediatric to adult healthcare settings are particularly challenging during later adolescence and early adulthood, and many young adults with T1D have long gaps in care that put them at higher risk for poor health outcomes, complications, and hospitalizations. There are few well-researched interventions to facilitate self-care and seamless transition between healthcare settings, and new approaches are needed to support young adults during this vulnerable period during which care is transferred. The goal of this line of research is to evaluate a translatable peer support intervention that can strengthen young adults’ ability to follow self-management recommendations and establish T1D care with an adult provider in a timely way to promote optimal health outcomes.